Erythropoietin treatment for anemia and hematopoietic/erythroid progenitor cell responses

Erythropoietin is required for red blood cell production and a role for nitric oxide (NO) to increase erythropoiesis is suggested in animal models of chronic stress and in hydroxycarbamide induction of human gamma-globin. We previously observed that erythropoietin protective activity in select non-erythroid tissue was mediated in part by NO production by NO synthase. Erythropoietin neuroprotection and cardio-protection in animal models required activity of neuronal NO synthase (nNOS) and endothelial NO synthase (eNOS), respectively. We used in vivo mouse models of erythropoietin stimulated erythropoiesis and ex vivo primary erythroid progenitor cell cultures to demonstrate the differential role of eNOS and nNOS in erythropoietic response to erythropoietin treatment.

Hematocrit level in eNOS knockout (eNOS-/-) mice were comparable to wild type mice, and erythropoietin treatment resulted in comparable erythropoietic response and increase in hematocrit. In contrast, nNOS-/- mice exhibit a blunted erythropoietic response to erythropoietin administration with a smaller increase in hematocrit. Erythroid colony assays of cultured bone marrow cells from eNOS-/-, nNOS-/- and wild type mice yielded comparable numbers of colonies at low erythropoietin concentration. At high erythropoietin concentration, colony numbers and size significantly increased in bone marrow cultures from wild type and eNOS-/- mice. However, erythroid colonies in bone marrow cultures from nNOS-/- mice remained small and fewer in number at high erythropoietin concentration. These erythroid culture studies provided evidence of an intrinsic defect in hematopoietic stem cells from nNOS-/- mice that compromises the erythropoietic response when exposed to high erythropoietin concentration. Mouse transplantation of hematopoietic stem cell containing bone marrow into wild type recipient mice was used to demonstrate the response of hematopoietic stem cells from nNOS-/- mice high dose erythropoietin treatment in vivo compared with wild type transplanted hematopoietic stem cells. Bone marrow harvested from nNOS-/- donor mice and from wild type donor mice was transplanted into wild type recipient mice with busulfan conditioning. The level of engraftment achieved was comparable in transplants from nNOS-/- mice and from wild type mice. Erythropoietin treatment increased hematocrit in all transplanted mice, and mice transplanted with wild type bone marrow reached a higher hematocrit than mice transplanted with nNOS-/- bone marrow. The decreased erythropoietic with erythropoietin stimulation in mice transplanted with nNOS-/- bone marrow supports the hypothesis that nNOS activity in hematopoietic/erythropoietic progenitor cells contributes directly to erythropoietin stimulated erythropoiesis and expansion of the erythroid lineage during erythroid differentiation.
Cultures of human peripheral blood CD34+ hematopoietic cells and other erythropoietin dependent erythroid cell lines showed induction of nNOS expression during erythropoietin stimulated erythroid differentiation and that modification of nNOS activity adversely affected proliferation and expansion of the erythroid lineage. Future studies will examine cross talk between erythropoietin and nitric oxide synthase pathways during erythroid differentiation of primary human hematopoietic progenitor cells in culture and in mouse models with modified erythropoietin signaling and/or modified nitric oxide synthase activity.

In the bone marrow, erythropoietin receptor is expressed in hematopoietic and non-hematopoietic cells including bone marrow stromal cells. In contrast to the protective activity of erythropoietin in select animal models of brain, heart and skeletal muscle injury, erythropoietin adversely affected bone health. Erythropoietin stimulated erythropoiesis in mice is accompanied by bone loss mediated by non-erythroid erythropoietin receptor expression in bone marrow stromal cells, especially osteoblasts. An in vivo bone formation assay using transplantation of bone marrow stromal cells absorbed onto a collagen scaffold demonstrated that that high dose erythropoietin directly affects bone marrow stromal cell adipogenesis and osteogenesis and compromises the ability to form bone ossicles. Analysis of U.S. Renal Data System (USRDS) datasets revealed a previously unrecognized adverse impact of EPO dose on bone fracture risk in hemodialysis patients, adding support to minimize erythropoietin dose in anemia treatment.

Full knowledge of the erythropoietic and non-erythroid activities of erythropoietin and potential interacting pathways will be informative to increase awareness of possible off-target effects associated with high dose erythropoietin and for development of erythropoietin derivatives or combination therapy for specific erythroid or non-erythroid erythropoietin response.